DEARC - Administrative Core

PROJECT SUMMARY/ABSTRACT
ADMINISTRATIVE CORE
The Administrative Core provides leadership and support to promote the highest quality research in the
Developmental Exposure Alcohol Research Center (DEARC) and its scientific impact. The goals of the
Administrative Core are to facilitate interactions among projects and attain research excellence throughout the
DEARC by providing clear leadership, efficient management, effective committee structure, strong
administrative, fiscal and research infrastructure, and to promote integration of projects and synergistic
outcomes. These goals are supported through 5 aims. Aim 1 provides an organizational infrastructure to
facilitate attainment of Center goals and objectives through a strong Executive Committee, aided by an efficient
DEARC office and administrator, capable fiscal support through the State University of New York Research
Foundation, as well as strong institutional support and an impressive research infrastructure. Building on the
culture of collaboration within the DEARC, Aim 2 promotes communication, facilitates interactions and
encourages integration and synergisms across the DEARC through such activities as monthly meetings, mini-
retreats, DEARC-sponsored colloquia, and a yearly retreat. Aims 3 and 4 are to ensure oversight, coordinate
interactions among research projects and cores, promote research-supportive allocation of resources, and
utilize internal and external guidance committees to ensure quality and progress of research components and
cores. Day-to-day decisions will be made by the center leadership with frequent consultation of a Steering
Committee and oversight by two critical guidance systems: an Internal Advisory Board (IAB) comprised of
senior administrators at Binghamton University, and a Program Advisory Committee (PAC) comprised of five
prominent senior alcohol researchers who serve as an external scientific advisory board to evaluate and advise
the DEARC regarding all aspects of Center functioning. Aim 5 is to encourage enrichment at all career levels,
promote the recruitment of new researchers in the field of alcohol and development, and enhance outreach
efforts by DEARC investigators. The Administrative Core is therefore critical for seamless and effective
integration of projects, as well as smooth and efficient operations of the DEARC as a whole.